COVID-19 Pandemic: Natural Experiment in Telehealth on Buprenorphine Treatment in a Large Integrated Healthcare System

PROJECT SUMMARY/ABSTRACT
Expanded use of telemedicine for buprenorphine prescribing may reduce barriers to buprenorphine prescribers.
However, federal regulations that require prescribers to conduct in-person medical evaluations to induct patients
on buprenorphine and limit maintenance visits to real-time, two-way, interactive audio-visual communication (i.e.,
telehealth) has prevented research on the potential role of expanding telehealth for buprenorphine prescribing.
The initial surge of COVID-19 cases in the US in March 2020 led federal agencies to ease the in-person
evaluation requirement, allowing providers to use telemedicine or telephone-only visits for medical evaluations
to start patients on buprenorphine. We propose a study that leverages these COVID-related regulator reforms
to answer important clinical and policy questions regarding the regulations governing the use of telehealth for
buprenorphine initiation and treatment among Veterans Administration (VA) patients. Serving ~5,000,000
patients each year, we will leverage the VA electronic health record data to answer three important clinical and
policy questions. (1) What was the effect of the relaxed buprenorphine prescribing guidelines on buprenorphine
treatment rates change during the COVID-19 pandemic overall and by treatment stage (new patients vs. long-
standing patients)? (2) What is the effect on treatment outcomes of more flexible telehealth regulations on
patients initiating buprenorphine treatment? (3) What is the effect of telehealth use on treatment outcomes on
patients in long-standing buprenorphine treatment (in care ≥6 months)? We will answer these questions in three
steps: (1) We will use time-series methods to model the monthly counts of VA patients in buprenorphine
treatment prior to March 2020, predict the monthly count in treatment from April to December 2020 and compare
it to the observe counts to quantify the change in buprenorphine treatment rates associated with more flexible
treatment regulations; (2) Test whether: (a) clinical treatment outcomes in patients initiating buprenorphine via
telehealth post-Policy changes differ from patients initiating treatment in the year before the outbreak and (b)
Investigate individual, facility, and area-level modifiers of the policy effects on clinical treatment outcomes; and
(3) Among long-standing patients: (a) Examine the relationship between telehealth use and clinical treatment
outcomes and (b) Determine individual, facility, and area-level differences in telehealth buprenorphine treatment.
Determining the effects of more flexible telehealth regulations will provide critical information on a potential policy
lever to increase access to critical life-saving medications for OUD. The complementary training program
comprising of formal courses, workshops, directed readings, and experiential learning will let me develop the
skill and expertise to launch my career as a substance use epidemiologist and prepare me to successfully
compete for R01 funding as an independent investigator with a focus on understanding the causes of addiction
and policy evaluation to inform interventions, prevent, and treat OUD and its related harms.

Public health relevance
PROJECT NARRATIVE Federal regulations requiring prescribers to conduct in-person medical evaluations to induct patients on buprenorphine and limit maintenance visits to real-time, two-way, interactive audio-visual communication (i.e., telehealth) have prevented research on the potential role of expanding telehealth for buprenorphine prescribing and the ability of this expansion to close the opioid use disorder (OUD) treatment gap in the US. This project will leverage the more flexible buprenorphine maintenance policies instituted during the COVID-19 pandemic to answer important clinical and policy questions regarding the regulations governing the use of telehealth for buprenorphine maintenance treatment. Results will inform policies to increase access to medications for OUD and future studies on how to reduce the OUD treatment gap.